Mentored implementation science research in asthma

PROJECT SUMMARY/ABSTRACT
The goal of this K24 Mid-Career Investigator award is to provide resources, training and protected time to
strengthen and expand Dr. Michelle Eakin's mentoring program that is focused on patient-oriented
implementation science. Asthma is the third leading cause for hospitalization in children and the leading cause
of school absenteeism in the US. Children from marginalized backgrounds at increased risk for asthma
prevalence and morbidity. Despite a strong evidence-base for the efficacy of asthma care programs in
reducing asthma morbidity, little progress has been made implementing and sustaining interventions in at–risk
communities. Effective interventions require a multi-level approach, and requires engaging community settings
such as schools and Head Start programs. These settings are an ideal location for reaching children given the
strong connection to families and trust from communities. However, often these low resource settings have
limited staff capacity with high rates of burnout which can lower implementation success. Although limited
staffing has been noted as a prominent barrier to implementation, there has been relatively little focus or
research on how to adapt to overcome this barrier in community settings to improve implementation success.
This K24 will leverage ongoing data collection in two NHLBI funded R level projects to evaluate the role of
burnout and burden on implementation of asthma programs in school settings. Dr. Eakin is an ideal candidate
to provide mentorship in this area based on her expertise in qualitative methods, implementation science and
asthma management programs. Dr. Eakin has a strong and growing record of successful mentorship in
implementation science across different settings and populations. This K24 award will allow Dr. Eakin to
expand her mentoring skills by including trainees from graduate to post graduate training to evaluate burnout
and staff burden as a determinant of implementation success and evaluate change in staff wellbeing
throughout the implementation process in low resource high stress educational settings. As part of this award,
Dr. Eakin will participate in training activities including one and on meetings with mentors, local workshop on
master mentoring and structured curriculums on K-to R transition. Dr. Eakin will refine her skills in qualitative
methods with advanced training on rapid qualitative approaches. The scientific goal of this project is to
investigate the role of staff burnout on implementation success using staff surveys and qualitative methods. Dr.
Eakin's scientific aims and training plan will provide an outstanding environment for training of researchers
focused on implementation science in a range of settings.

Public health relevance
PROJECT NARRATIVE In order for asthma management interventions to have broad public health impact, the interventions need to be implemented in community settings to reach children who are at greatest risk. However, these community settings are often low resourced and have high rates of staff burnout, which could be an important determinant of implementation success. This award will enhance the success of the principal investigator in training scientists in implementation science and ways to address burnout by providing her with the needed mentoring, resources and protected time, which will contribute to advances in implementation science and public health.